Machine Learning Prediction of Persistent Adverse Mental Health Outcomes for Autistic Children: Leveraging Social Determinants of Health from Clinical Data

PROJECT SUMMARY/ABSTRACT
Autistic children and youth have high utilization of emergency department visits and inpatient stays for
psychiatric indication. There is a need to understand who is at the greatest risk for adverse mental health
outcomes in order to tailor prevention efforts. However, autism research to date has rarely incorporated social
determinants of health (SDoH), which are social factors that significantly impact physical and mental health.
Although SDoH account for up to 50% of health outcomes, they remain largely unstudied in autism research,
and uncaptured in electronic health record (EHRs). The proposed research addresses these gaps by
leveraging SDoH to predict the risk of persistent adverse mental health outcomes for autistic children and
youth, ultimately improving clinician and health system responses to patients' SDoH-related needs. In this
multimethod study, we will use EHR data from Children's Hospital Los Angeles (CHLA) and the University of
Florida Health System (UF Health) to (1) identify ecological- and individual-level SDoH factors within EHRs,
using natural language processing (NLP) to extract individual-level factors from clinical notes; and (2) build
machine learning risk prediction models for persistent adverse mental health outcomes, investigating the
additive effect of SDoH (compared to demographic/clinical characteristics). We will use a qualitative design to
(3) explore clinician perspectives on utilizing SDoH within EHRs in clinical care, and gather clinician response
to our prediction model, presented at Grand Rounds, to create action steps for both sites. We will elicit
stakeholder input throughout the study from a Community Advisory Board made up of autistic adults and
caregivers of autistic children and youth. By incorporating SDoH, we will be able to predict which autistic
children and youth are at highest risk for persistent adverse mental health outcomes, and identify how
clinicians can practically use SDoH to improve care. This will facilitate the `meaningful use' of SDoH in EHRs
and ultimately improve equity in mental health service access and outcomes for this vulnerable population.

Public health relevance
PROJECT NARRATIVE Autistic children and youth are at high risk for adverse mental health outcomes, but efforts to understand the nuances of this risk are stymied by a lack of autism research investigating social determinants of health (SDoH), or social factors that significantly impact physical and mental health. With support from a Community Advisory Board made up of autistic adults and caregivers of autistic children, we will use electronic health record (EHR) data from Children's Hospital Los Angeles (CHLA) and the University of Florida Health System (UF Health) to (1) identify ecological- and individual-level SDoH factors within EHRs and (2) build machine learning risk prediction models for persistent adverse mental health outcomes; and a qualitative design to (3) explore clinician perspectives on utilizing SDoH within EHRs in clinical care. By incorporating SDoH, we will be able to predict which autistic children and youth are at highest risk for persistent adverse mental health outcomes, and identify how clinicians can practically use SDoH to improve care.